Biogenesis and function of cyclic phosphate-containing RNAs

Project Summary and Abstract
Short non-coding RNAs (sncRNAs) possess a wide range of functions and are indispensable to many biological
processes. While the best characterized sncRNAs are those associated with Argonaute family proteins, such as
microRNAs (miRNAs) and PIWI-interacting RNAs (piRNAs), recent research has uncovered other functional
sncRNA classes with distinct properties, biogenesis, and functions. During the biogenesis of sncRNAs,
enzymatic cleavages of precursor molecules leave various terminal formations, such as hydroxyl (OH),
phosphate (P), or 2′,3′-cyclic phosphate (cP). However, the majority of RNA-seq data for sncRNAs to date has
been generated using standard RNA-seq methods, which predominantly capture sncRNAs with 5′-P and 3′-OH
ends, like miRNAs. SncRNAs with other terminal structures cannot be ligated to the 5′- and/or 3′-adaptors, and
thus remain unrecognized by standard RNA-seq methods. This limitation results in the exclusion of non-miRNA-
sncRNAs lacking the 5′-P/3′-OH ends from expression analyses, keeping them uncharacterized. This study
specifically focuses on short cP-containing RNAs (cP-RNAs) which contain a cP at their 3′-end and thus are
absent in standard RNA-seq data. Despite being largely undetected in standard RNA-seq analyses, numerous
cP-RNAs have been identified as functional sncRNAs. A representative example is the 5′-tRNA halves produced
through anticodon cleavage of tRNAs by the angiogenin endoribonuclease. These cP-RNAs play significant roles
in various biological processes, including stress response, cell proliferation, and immune response. By
developing cP-RNA-seq, which can specifically sequence cP-RNAs, we have performed a genome-wide
expression analysis of short cP-RNAs across various cells and tissues, revealing that: 1) cP-RNAs are generated
not from random degradation but through regulated biogenesis pathways; 2) cP-RNAs constitute a significant
portion of sncRNAs (15–60 nucleotides) in cells, tissues, and in extracellular vesicles; and 3) expression levels
and profiles of cP-RNAs are regulated by various factors such as hormone signaling pathways, aging, oxidative
stress, and infection. We propose cP-RNAs as promising research subjects due to their diverse physiological
functions in various biological processes. Moving forward, our research will focus not only on identifying which
cP-RNAs are expressed, but more importantly on understanding the regulation of their biogenesis and
elucidating their molecular functions. Recently, we have discovered RNase Kappa as a novel enzyme generating
cP-RNAs, along with two new proteins that interact with and stabilize cP-RNAs. Our proposed study will involve
characterizing the roles of these factors in the regulation of cP-RNA expression and investigating the functional
significance of their generated/stabilized cP-RNAs in piRNA biogenesis, regulation of mRNA stability, and
immune receptor activations during immune response, which will help achieve our goal of understanding cP-
RNA biology and realizing its broader implications for human health and disease.

Public health relevance
Project Narrative Short non-coding RNAs (sncRNAs) play crucial roles in various biological processes, yet the cyclic phosphate- containing RNAs (cP-RNAs) within this group remain largely uncharacterized due to limitations in standard RNA- seq. This study will employ our developed cP-RNA-seq to elucidate the biogenesis and functions of cP-RNAs. We aim to characterize novel enzymes responsible for cP-RNA production, and to determine their roles in the regulation of mRNA stability and immune responses, advancing our understanding of cP-RNA biology and its implications in human health and disease.